Bioinformatics Core

Bioinformatics Core – Summary
The mission of the Bioinformatics Core is to provide bioinformatics support and training for investigators
within the Vermont Genetics Network (VGN). The Core provides computational analysis of life sciences data for
all investigators in the VGN network. Many experimental methods produce large data sets requiring the use of
computational tools to fully analyze them. Modern instruments employed in research projects such as whole
genome sequencing or cancer biomarker discovery produce protein, RNA and DNA data sets that are too large
to be analyzed by most bench scientists. The Bioinformatics Core works with investigators and their students to
provide analyses that help answer questions related to their experimental data.
The Bioinformatics Core utilizes a large computer server coupled to a large data storage array for most
bioinformatics work. The internal infrastructure yields a very cost effective solution for providing bioinformatics
services. Internal controls are developed on a per project basis to ensure high quality results for all
investigators.
The Core provides experimental design, power analysis, and data analysis in genomics, transcriptomics
and proteomics. Specifically, the Core assists users from VGN Baccalaureate Partner Institutions (BPI) and UVM,
as well as others, in proteomics informatics, genomics and biostatistics analysis, functional analysis, software
and database development, as well as training in bioinformatics and access to shared resources.
The Administrative Core will assess performance and the Bioinformatics Core’s impact on the VGN
mission. It will assist with implementation of best practices identified by the external evaluator, Dr. Joy
Livingston, the Internal Steering Committee, the External Advisory Committee, and the AAAS Research
Competitiveness Program consultants.
The Bioinformatics Core provides a high level of expertise in bioinformatics, ensuring the support needed
to design, conduct, analyze, interpret, and manage results requiring or facilitated by informatics applications.
Continuing to provide these services to our BPIs and through the State of Vermont in INBRE 4 will promote a
culture of research.